Virus Production & Molecular Biology Core

Virus Production & Molecular Biology Core
Project Summary
The Virus Production & Molecular Biology Core module will provide the means to incorporate modern
molecular and genetic techniques into the programs of vision research investigators at Yale. First, the Core
module will supply virus preparation assistance and related services for laboratories working with transgenic
animals and/or viral techniques. Second, the Core module will train new investigators and students in basic
molecular biology techniques, including DNA modification to generate new viral vectors, as well as
histological techniques, such as immunostaining. Third, it provides and maintains a range of molecular
biology equipment to be shared among vision researchers who lack such equipment in their own
laboratories. Viral vectors are powerful tools for gene delivery in terminally differentiated cells. For example,
adeno-associated viruses (AAVs) have enjoyed increasingly wide application in vision research based on
their many favorable features that include the lack of pathogenicity, low immunogenicity, and the ability to
maintain long-term transgene expression in neurons. The Virus Production & Molecular Biology Core
module will be capable of providing both AAV vector design and production to meet a variety of research
needs among vision researchers at Yale. An in-house capability for virus design and production will
significantly enhance vision research by producing custom, high-titer AAV products not available from
commercial sources. Consultation and training in molecular, genetic and histological techniques will expand
the research capabilities of vision researchers that lack sufficient background in these areas with the
convenience of in-person consultation for specific research needs.